Defining the antigenic determinants of the adaptive immune response in IgG4-related disease

This mentored research program aims to develop Dr. Perugino into an independent investigator studying the
immunologic mechanisms of fibrosis. The research goals entail the identification of specific self-proteins driving
adaptive immune responses in the context of IgG4-related disease (IgG4-RD), a recently described immune-
mediated fibrotic disease. Candidate: Dr. Perugino is a junior faculty member in the Rheumatology Unit at
Massachusetts General Hospital and has been conducting bench-based research since 2015. His short-term
career goals are to build a stronger foundation in molecular biology, advance his skills in statistical analysis,
develop proficiency in single-cell sequencing, gain expertise in creating and screening peptide-MHC yeast
display libraries, and build his professional skills towards independent investigation. These goals will be
supported by a series of coursework through Harvard University and the Harvard Clinical and Translational
Science Center. He has recently published four first-author papers, the first identifying galectin-3 as a novel B
cell self-antigen in IgG4-RD (Journal of Allergy and Clinical Immunology, 2019), the 2nd linking the diversity of
auto-antibody responses with disease severity in IgG4-RD (Arthritis & Rheumatology, 2019), a 3rd establishing
CD4+ T cells with cytotoxic features as likely disease drivers in systemic sclerosis (Journal of Clinical
Investigation, 2020) and a 4th establishing the effector phenotype of cytotoxic CD4+ T cells in IgG4-RD (Journal
of Allergy and Clinical Immunology, 2020). This work forms the foundation for this K08 proposal. Mentorship,
Training Activities, and Environment: Dr. Perugino has been under the direct mentorship of Dr. Shiv Pillai since
2015 and Dr. John Stone since 2014 acting as mentors in investigation and translational research, respectively.
The training plan builds upon the skills learned under this mentorship team. Guided by his advisors and
collaborators, Dr. Perugino will gain proficiency in (1) single cell RNA sequencing (Dr. Alex Shalek), (2) Ig/TCR
repertoire analyses (Dr. Mark Davis), (3) peptide-MHC yeast display library development (Dr. Michael Birnbaum),
immune cell interactions (Dr. Michael Brenner) and biostatistical analysis (Dr. Musie Ghebremichael). Research
Program: The overarching hypothesis of this proposal is that the immune response in IgG4-RD is driven by the
crosstalk between B and T cells directed at specific epitopes derived from the same protein antigen. Leveraging
the identification of clonal expansions of B and T cells in IgG4-RD, the proposal entails the determination of
dominant B and T cell clones, which will subsequently be used to single cell clone soluble antigen receptors and
use those as probes to pull down their cognate antigens. These complementary approaches, one focused on B
cells (Aim 1) and the other on T cells (Aim 2), entail the validation of B and T cell responses among the largest
single-center cohort of IgG4-RD bio-samples in the United States. These studies will serve as a foundation for
Dr. Perugino's future goals of identifying the HLA and antigenic determinants that distinguish the clinical
phenotypes of different immune-mediated fibrotic diseases, such as IgG4-RD, as an independent investigator.

Public health relevance
Project Narrative IgG4-related disease is an autoimmune fibrotic disorder that affects multiple organs and causes tumor-like masses, often misdiagnosed as metastatic cancer. Thus far, we have determined which types of immune cells are likely drivers of the disease, but the proteins driving this response and whether they are self or foreign, remain largely unknown. The knowledge gained from this research is hoped to lead to a more in-depth ability to learn how immune cells interact with each other in causing fibrosis.